An Imaging Repository for the Cerebrovascular Disease Knowledge Portal (iCDKP)

PROJECT ABSTRACT
Stroke is the world’s second-leading cause of death. By 2030 an estimated 122.4 million people world-wide will
be affected while stroke-related medical costs in the US alone are projected to exceed $180 billion. Furthermore,
stroke itself is only the most acute manifestation of cerebrovascular disease, which also causes chronic
progressive deterioration in brain function, including vascular contributions to cognitive impairment and dementia
(VCID). Despite a pressing need for novel treatments, the precise biological pathways that lead to brain ischemia
and hemorrhage, the response of the brain to injury, and the brain’s capacity for recovery remain poorly
understood. Imaging provides crucial and quantifiable measures of these processes. Without imaging it is
impossible to characterize the location of the brain affected, quantity of brain tissue involved, or amount of brain
swelling/edema. Furthermore, serial images of the same patient over time capture dynamic physiology such as
infarct growth or hemorrhage growth, which are both crucial to studying injury and recovery. The International
Stroke Genetics Consortium (ISGC) was founded to harness human genetics to identify novel biological
pathways that can ultimately lead to effective treatments for stroke. Indeed, candidate drug treatments supported
by evidence from human genetics are substantially more likely to achieve FDA approval. The ISGC’s
commitment to large harmonized data sets, open data sharing and collaborative culture has led to the discovery
of all of the robustly supported risk genes for common forms of stroke to date, many of which are already being
studied as the basis for novel treatments. In 2017 the ISGC launched the Cerebrovascular Disease Knowledge
Portal (CDKP) (R24NS092983) to share genetic data freely with the research community in a manner adherent
to FAIR Data Principles. A major limitation of this resource is the absence of brain images. For this proposed
biomedical data repository cooperative agreement (U24) we will aggregate brain imaging and genetic data
according to FAIR data principles from an estimated 30,000 individuals with stroke and share these data
according to FAIR data principles. Building on the established Stroke Neuro-Imaging Phenotype Repository
(SNIPR) at Washington University, our program will transform the CDKP into the imaging CDKP (iCDKP),
providing the global community with a single FAIR access point to genetic, phenotypic, and imaging data.
Milestone-driven aims will: 1) Aggregate high value stroke imaging datasets from across the international
investigator community; 2) Implement FAIR data sharing practices and procedures; 3) Engage the research
community with repository. Our team, led by the PIs for CDKP and SNIPR is well-situated to execute this project
given that we have developed this proposal in consultation with the international stroke research community to
ensure broad support and maximum response to their anticipated needs.

Public health relevance
PROJECT NARRATIVE Sharing the brain images and genomic data from stroke patients provides a unique resource to discover new treatments that can reduce the injury caused by strokes, if we can make the images findable, accessible, interoperable, and reusable (FAIR) so that investigators from around the world can study them. With prior NIH support we built the Cerebrovascular Knowledge Portal (CDKP) to share genetic data. We now propose to build the imaging CDKP (iCDKP) to enable investigators to study these data for insights that will someday lead to new treatments that can prevent strokes, reduce the damage a stroke causes, or help the brain recover from a stroke.